Role of Gut Microbial Translocation in Initiating Autoimmunity

Genetic and environmental factors contribute to systemic lupus erythematosus (SLE). Previous studies showed
environmental factors such as bacterial products or their-induced inflammatory mediators (e.g., IFN-α) are
involved in SLE pathogenesis. Previous studies from others and we revealed that multiple autoAbs are more
commonly detected in first-degree relatives of lupus patients (FDRs), compared to unrelated healthy controls
(UHCs). In addition, FDRs have heightened levels of inflammation (e.g., B lymphocyte stimulator (BLyS), and
IFN-α) associated with TLR stimulation and B cell activation compared with UHCs. It is unclear the initial trigger
for autoantibody production. This lack of understanding of early events in development of autoimmunity is a
critical barrier for disease prevention. FDRs, rather than patients, provide a study population, genetically prone
and possibly environmentally exposed, who are not on immune modulatory drugs nor impacted by disease,
allowing conclusions less confounded by external factors.
In preliminary studies, we found: 1) increased presence and diversity of autoAbs in healthy FDRs of lupus
patients compared to unrelated healthy controls (UHCs); 2) increased microbial product translocation (plasma
LPS) associated with elevated plasma autoAb levels (anti-dsDNA, anti-ssDNA, and anti-nucleosome); and 3)
decreased plasma microbial diversity in FDRs with enrichment of the family Streptococcaceae and genus of
Streptococcus product translocation in UHCs and relative enrichment of Pseudomonas product translocation in
FDRs relative to UHCs. Recently SNPs in the coding region of two genes that mediate gut permeability were
identified as associated with lupus disease risk. We hypothesize that increased gut microbial product
translocation and its-associated inflammation in FDR individuals, a result of a “leaky” gut, serve as
initiators for autoAb production and later SLE development. In the current study, we will recruit matched
UHCs, FDRs, and lupus patients. A “leaky” gut leading to systemic bacterial products and autoAb induction in
the pathogenesis of lupus represents a novel mechanism to explain disease initiation in susceptible genetic high-
risk individuals.
Specific Aim 1: Determine intestinal barrier integrity, systemic bacterial product translocation, and its
mediated inflammation in the activation of B cells. We hypothesize that plasma autoAb levels are associated
with intestinal barrier integrity, inflammation and systemic bacterial products. In vivo gut permeability tests,
plasma LPS and total bacterial rDNA levels, plasma TLR-related inflammation (e.g., IL-6 and IFN-α), B cell
subset activation and a series of lupus-related autoAbs (e.g., anti-dsDNA and anti-nucleosome IgGs) will be
assessed in patients, FDRs and UHCs.
Specific Aim 2: Determine systemic and mucosal microbial components and the effect of certain
bacterial product translocation on autoantibody production. We have observed relative enrichment of
Pseudomonas products in plasma of FDRs relative to UHCs. Comparisons between systemic and mucosal
microbiomes has not been reported previously in lupus patients, FDRs or UHCs. We therefore will assess the
systemic and mucosal microbiome and identify the role of microbial translocation in autoAb production and lupus
disease in both human and mouse studies.
In the current study, we propose to investigate a novel mechanism for autoAb production and SLE etiology. We
believe that a broad array of TLR agonists, from a “leaky” gut, are the fundamental drivers of autoAb initiation.
This work will provide insight into the potential of a therapeutic strategy targeting mucosa or particular bacteria
to prevent autoAbs and disease onset.

Public health relevance
It is known that genetic and environmental factors contribute to the development of lupus. It is also clear that first degree relatives (FDRs) of lupus patients have an increased risk of developing lupus and also have a higher prevalence of lupus related autoantibodies than unrelated healthy controls. Autoantibodies develop years prior to disease onset in most patients. The initiators of autoantibody production, the first step in lupus pathogenesis are unclear. We hypothesize, based on recent genetic risk factor identification, and our findings from the prior funding period, that a “leaky gut” (more prevalent in women than men), allows increased microbial product translocation leading to exposure of the mucosal and systemic immune systems to inflammatory mediators. Using low dose LPS, we propose to test our hypothesis by assessing gut mucosal integrity, systemic levels of microbial products and their effects on B cell activation in lupus patients, FDRs, UHC and in murine models of disease. Results of these studies may provide novel insight into disease initiation and new treatment approaches.